Immunotherapy of prostate cancer using an anti-CD6 monoclonal antibody

PROJECT SUMMARY/ABSTRACT
Limitations of checkpoint inhibitor cancer treatment include precipitation of autoimmunity and resistance to
immunotherapy. For some cancers, notably prostate, lymphocytes are unable to infiltrate the cancer
microenvironment. Therefore, new approaches and targets are required. Here we present CD6, a cell surface
glycoprotein expressed by most T-lymphocytes and human natural killer (NK) cells, that engages in cell-cell
interactions by binding to its ligands CD166 (ALCAM) and CD318 (CDCP1). CD6-/- and CD318-/- mice are
healthy and are resistant to induction of T cell dependent autoimmune models of multiple sclerosis, uveitis and
rheumatoid arthritis. Moreover, in CD6-humanized mice a monoclonal anti-human CD6 antibody that we
developed, termed UMCD6, is a strikingly effective treatment for these autoimmune conditions. Both CD166
and CD318, the two ligands of CD6, are highly expressed by many cancers, and expression of CD318
correlates with aggressiveness and metastasis for many types of human cancers including prostate cancer.
CD318 can also be shed by cancer cells, and its soluble form (sCD318) is chemotactic for NK cells and T cells.
We have recently found that prostate cancer cell lines hyper-express and hyper-shed sCD318, creating a
gradient that will halt lymphocyte migration prior to entry into the tumor microenvironment. Additionally, we
tested the effect of blocking the CD6-CD318 axis with UMCD6 on the ability of human lymphocytes to kill
human prostate cancer cells. We found that UMCD6 enhanced lymphocyte-mediated prostate cancer cell
death and reduced cancer cell survival.
We hypothesize that UMCD6 acts directly on CD8+ T cells and NK cells and can produce a complete response
in vivo of human prostate cancer in immune deficient mice. We also propose that UMCD6 orchestrates
prostate cancer cell death by extensive alteration of gene expression in NK cells and CD8+ T cells, thereby
“licensing” these cells to kill cancer cells more aggressively. We will evaluate the efficacy of UMCD6 using
repeated administration of UMCD6 and human lymphocytes to treat human prostate cancers xenografted into
scid-beige mice. We will also demonstrate that high concentrations of sCD318 shed from prostate cancer can
exclude lymphocytes from entering prostate cancers in vivo, unless CD6 is internalized. To verify that the in
vivo mechanisms of the anticancer effects of UMCD6 reflect the pattern of altered gene expression in
lymphocytes in vitro, we will perform single cell RNA-seq and multicolor flow cytometry on tumor-infiltrating
lymphocytes (TILs). We will also assess the significance of upregulated stimulatory receptors by using blocking
antibodies against these receptors in cancer cell killing assays. These experiments are structured to provide a
compelling rationale for advancing CD6-targeted immunotherapy into clinical trials in human prostate cancer.

Public health relevance
PROJECT NARRATIVE This proposal explores an approach to prostate cancer immunotherapy using a monoclonal antibody that binds to a molecule on lymphocytes known as CD6, which would, distinct from currently available checkpoint inhibitors, suppress rather than instigate serious autoimmune toxicity.